Synthetic replicas of TDP-43 filaments associated with frontotemporal dementia

The key histopathological feature of frontotemporal lobar degeneration (also known as frontotemporal
dementia) and amyotrophic lateral sclerosis is accumulation of aggregated TDP-43 protein in brain. Similar
aggregates (filaments) are also associated with a number of other neurodegenerative diseases, including
Alzheimer's disease, dementia with Lewy bodies, hippocampal sclerosis and chronic traumatic
encephalopathy. An important recent development in the field was determination, by cryo-electron
microscopy, of high resolution structures of these TDP-43 filaments derived from brains of individuals
afflicted with two different types of frontotemporal lobar degeneration. The overall goal of this exploratory
research is to develop and experimental model and establish conditions for generation of amyloid fibrils
with structures identical to those of brain-derived filaments from the recombinant TDP-43 in vitro. Upon
initial screening by low resolution methods, structural similarity of selected synthetic fibrils to brain-derived
filaments will be verified at a high-resolution level by cryo-electron microscopy. Generation of synthetic
replicas of TDP-43 filaments associated with different phenotypes of the disease would represent a very
important development: it would not only provide a stepping stone for mechanistic studies on disease-
relevant TDP-43 aggregation pathways, but also open new avenues for development of drugs (TDP-43
aggregation inhibitors, disaggregating agents) as well as diagnostic tools for early detection of TDP-43
proteinopathies in patients.

Public health relevance
Frontotemporal degeneration and some other neurodegenerative diseases are associated with deposition of abnormal aggregates (filaments) of TDP-43 protein in brain. Generation of structurally identical filaments in the test tube is of major importance, as it will allow studies on the mechanism of their formation as well as open new avenues for development of therapeutic and diagnostic agents.